The Role of Kisspeptin in Metabolism Regulation

PROJECT SUMMARY/ABSTRACT
Pregnancy is a physiological state of continuous and significant adaptation to changing maternal and fetal
nutritional needs ensuring successful completion of pregnancy at term. To this end, as pregnancy progresses,
the placenta produces multiple hormones that participate in modifying maternal metabolism to meet the
metabolic needs of both fetus and mother. Of the placental hormones, circulating kisspeptin1 (Kiss1) levels
progressively increase by several-hundred-fold during pregnancy. Although certain metabolic actions have been
assigned to Kiss1, little is known about how Kiss1 contributes to the metabolic adaptations of pregnancy.
In addition to developing insulin resistance, maternal hepatic glucose output (rate of appearance) increases
as does the propensity to developing hypoglycemia and ketosis even after short periods of fasting. The
mechanism underlying the tendency of the pregnant female to develop ketosis remains unknown. Further,
insufficient glucose and nutrient supply to the fetus poses a significant health risk for the developing child.
Based on our preliminary studies, we hypothesize that during gestation placenta-derived circulating Kiss1,
activates its cognate G-protein coupled receptor Kiss1R on hepatocytes and signals via Gaq-inositol
triphosphate receptors (IP3R) to activate AMPK (adenosine-monophosphate dependent kinase), lipolysis and
ketogenesis. Absence of Kiss1R in hepatocytes of female mice during pregnancy leads to excessive lipid
accumulation in maternal hepatocytes and to increased risk of hypoglycemia in the third trimester.
Furthermore, our preliminary studies indicate that the pancreatic hormone glucagon stimulates hepatic Kiss1
production, whereby Kiss1 acts in the liver in an autocrine manner. Absent liver Kiss1R, glucagon-induced IP3
production as well as hepatic glucose output are blunted in fasting mice, suggesting that kisspeptin induction is
an integral part of glucagon action in hepatocytes. These observations reveal a novel regulatory interplay
between glucagon and Kiss1 in regulating hepatic metabolic pathways.
We now seek to expand our novel and exciting findings specifically a) to understand the molecular
mechanisms that shape maternal liver metabolism in gestation; b) to understand different Kiss1R-IP3R signaling
pathways in regulating liver metabolism, and c) to understand the role of glucagon-stimulated kisspeptin
production by the liver in modulating liver metabolism during gluconeogenesis.
We will use complementary in vivo and in vitro approaches to elucidate these important signaling pathways
in hepatocytes using newly generated unique mouse models as well as in vitro in human hepatocyte cell lines.
Our studies will yield important insights into kisspeptin’s role in liver metabolism during eutherian pregnancy
and into how kisspeptin and glucagon signaling interplay in hepatocytes to regulate metabolism. Further, our
studies will dissect signaling pathways as potential therapeutic targets in metabolic liver disease and diabetes
mellitus.

Public health relevance
PROJECT NARRATIVE The role of placental hormones in securing metabolic homeostasis in the mother and fetus during pregnancy is poorly understood; and the potential role of placental hormones and other placental products in maintaining maternal health and treating metabolic disorders outside of pregnancy is insufficiently explored. The present proposal aims to understand the effects of the placental hormone kisspeptin in regulating liver metabolism as well as blood glucose homeostasis. The studies will also elucidate kisspeptin-activated signaling mechanisms in liver cells with the potential to identify novel targets for treating metabolic disorders.